UNC CASCADE Network Research Base

ABSTRACT
The Director-General of the World Health Organization has called for invasive cervical cancer (ICC) elimination
by 2030. Women living with HIV (WLWH) have a ~10-fold higher risk of ICC. There is an urgent need for high
quality evidence on optimal strategies for ICC prevention directly applicable to WLWH who face a disparate
burden of cervical precancer and ICC.
We will establish a CASCADE Network UG1 Research Base (RB) at the University of North Carolina-Chapel Hill
(UNC) to prevent ICC among WLWH. The overarching goal of this UNC RB proposal is to develop, test, and
implement effective, scalable, and cost-effective screening and treatment strategies to reduce ICC among
WLWH. We will develop, implement, and analyze innovative hybrid effectiveness-implementation trials in the
CASCADE Network focus areas of “Improving the Management of Screen Positives” and “Optimizing Precancer
Treatment”. The UNC RB will be composed of clinicians, epidemiologists, biostatisticians, and training experts
with decades of research experience on ICC prevention and HIV in both LMIC and the US. Our multi-disciplinary
team has expertise in implementation science, screening with automated visual evaluation (AVE), pathology,
and cost-effectiveness analyses.
In Aim 1, we will Develop CASCADE Network trials of evidence-based interventions to optimize the screening
for and management of cervical precancer among WLWH by 1) providing scientific, clinical and statistical
expertise to develop innovative concepts and protocols for novel, yet pragmatic, hybrid effectiveness-
implementation trials, and 2) creating organized processes to efficiently develop concepts and protocols by
leveraging diverse input from the UNC RB Scientific, Statistical, Clinical Sites Advisory, Patient Advocacy
Advisory, and Scientific Advisory Committees. As an illustrative example of a potential clinical trial for “Improving
Management of Screen-Positives”, we propose Protocol 1, a stepped wedge cluster randomized trial to Evaluate
AVE triage versus HPV-and-treat among HPV-positive WLWH for CIN2+ prevention. For “Optimizing Precancer
Treatment”, we propose Protocol 2, a Hybrid Type 1 trial to evaluate the effectiveness of adjuvant, self-
administered intravaginal topical therapy following primary 2/3 treatment to prevent CIN2+ recurrence among
WLWH. Outcomes for both trials will include clinical effectiveness for precancer, implementation outcomes, and
cost effectiveness analyses. In Aim 2, we will ensure successful Implementation and Analysis of CASCADE
Network trials by providing scientific, clinical and statistical expertise, operational support, and regulatory
oversight. In Aim 3, we will provide Rigorous Foundational Clinical and Research Training for UG1 Clinical
Sites and Early-Stage Investigators to design and implement clinical effectiveness research. If successful,
CASCADE Trial findings will advance clinical screening and treatment guidelines for WLWH in LMIC and United
States.

Public health relevance
PROJECT NARRATIVE Invasive cervical cancer disproportionately burdens women living with HIV (WLWH) and can be prevented with appropriate screening coupled with effective treatment of cervical precancerous lesions. We propose to establish a CASCADE Network UG1 Research Base at the University of North Carolina to develop, implement, and analyze hybrid effectiveness-implementation trials of innovative, yet pragmatic, strategies to reduce cervical cancer among WLWH. If strategies are found to be clinically effective, acceptable, and cost-effective, CASCADE Trial findings have potential to inform clinical practice guidelines to ultimately reduce cancer disparities among WLWH in the United States and low-and-middle income countries.